Serial IGRA testing of Tanzanian adolescents to detect TB in household contacts

PROJECT SUMMARY
Tanzania has one of the highest burdens of tuberculosis (TB) in the world. Achieving
global TB elimination under the 2035 End TB Strategy will require an expanded focus
on active TB case finding. A key component of the current case finding strategy is
testing household contacts (HCs) of new cases of remotely-acquired but recently
diagnosed TB disease (index case) to find HCs who may also have TB disease. Only
2-4% of households are typically found to have a previously undetected case of TB
disease. This is because TB disease typically requires 2-5 years to develop after
exposure and infection, suggesting that if transmission occurred in the household the
source HC may have already been treated, recovered or died from TB.
We hypothesize that testing HCs of recently acquired (incident) cases of TB infection
is likely to result in detection of a significantly higher proportion of HCs who were the
source of the adolescent infection and still have undiagnosed active TB disease.
In a recently completed 3-year prospective study in Tanzania we developed methods for
school-based serial testing of adolescents to detect newly acquired TB infection. The
trial used the T spot interferon gamma assay (IGRA) assay to detect new infection, and
determined that the annual rate of new infection was 2.9%. In the proposed 2-year
study we will screen 800 adolescent schoolchildren and follow the estimated 680 IGRA-
negative participants for 1.5 years to detect >25 new incident TB infections. We
hypothesize that the proportion of their 25 households (and their 100 HCs) with a
previously undetected case of TB will be as high as 14%, and will therefore identify a
new and more robust global strategy for active case finding. Control households will
include those of 25 adolescents with prevalent TB infection (100 HCs) and households
of 25 adolescents with no TB infection (100 HCs). The trial will be conducted under the
comprehensive DarDar Research Program, a 20-year research collaboration between
Muhimbili University of Health and Allied Sciences (MUHAS, Tanzania) and the Geisel
School of Medicine at Dartmouth (USA). This innovative study has the potential to
identify a game-changing strategy for more effective active TB case finding.

Public health relevance
Project Narrative If we are able to show that many adolescent schoolchildren with new TB infection have a previously undetected case of active TB disease in their household we will have fundamentally changed the understanding of TB transmission to adolescents. Very importantly this finding would lead to an innovative new public health method for active case finding of TB disease, a major goal of the global End TB strategy.